Role of Smooth Muscle-derived Vascular Progenitor Cells (AdvSca1-SM) in Vasa Vasorum Expansion and Atherosclerotic Plaque Progression

PROJECT SUMMARY/ABSTRACT
Atherosclerosis is a complex inflammatory disease and a major cause of morbidity and mortality worldwide, but
current therapies fail to adequately meet clinical needs. Until recently, most atherosclerosis research has focused
on endothelial activation, immune cell recruitment, and lipid retention within the intima, but emerging evidence
implicates the vessel adventitia in the pathogenesis of atherosclerosis. Specifically, it has been suggested that
expansion of adventitial microvessels, the vasa vasorum (VV), drives atherosclerosis progression by facilitating
inflammatory cell infiltration to the vessel wall and developing atheroma. This project focuses on the role that
smooth muscle-derived vascular progenitor cells, termed AdvSca1-SM cells, play in vasa vasorum expansion
and plaque neovascularization. Our lab previously identified AdvSca1-SM cells as a subset of resident vascular
progenitor cells reprogrammed from mature smooth muscle cells in situ in a Klf4 depended process. These cells
are enriched for genes in the hedgehog/Wnt/β-catenin pathways, particularly Gli1, and have multilineage
differentiation potential. In the setting of acute vascular injury, AdvSca1-SM cells expand robustly to contribute
to fibrotic remodeling, but it is unclear what role they play in chronic injuries such as atherosclerosis. Work from
several groups has suggested that adventitial progenitor cells can contribute to VV expansion, and our group
has previously demonstrated that AdvSca1-SM cells are capable of de novo vessel formation via endothelial or
smooth muscle cell differentiation in Matrigel plug assays. Additionally, we have identified AdvSca1-SM-like cells
in the microvessels surrounding human coronary arteries, suggesting a potential role in the VV. The aim of this
project is to determine the contribution of AdvSca1-SM cells to VV expansion, plaque neovascularization, and
atherosclerotic progression. We hypothesize that AdvSca1-SM cells are major contributors to atherosclerosis,
and that modulation of these cells could alter disease progression. Specific Aim 1 will define the functional
contribution of AdvSca1-SM cells to VV expansion and/or plaque progression using a highly specific AdvSca1-
SM genetic lineage tracing mouse model; AdvSca1-SM contribution will be assessed using immunofluorescent
microscopy and flow cytometry. Specific Aim 2 will define the mechanisms controlling AdvSca1-SM cells in the
setting of atherosclerosis, with an emphasis on the Gli/Wnt/β-catenin/Klf4 signaling axis previously identified as
a regulator of AdvSca1-SM cells in the setting of acute vascular injury. We will modulate this signaling axis using
AdvSca1-SM-specific Gli1 overexpression or Klf4 knockout; the effects of these modifications on AdvSca1-SM
maintenance or differentiation will be assessed using immunofluorescent microscopy, flow cytometry, and single
cell RNA-seq. Ultimately, the work proposed here represents a novel avenue of research that will help fill the
current knowledge gap regarding the role AdvSca1-SM cells play in the atherosclerotic disease process.

Public health relevance
PROJECT NARRATIVE Atherosclerosis is a complex inflammatory disease and a major cause of morbidity and mortality worldwide, but current therapies fail to adequately meet clinical needs. The preliminary results shown in this proposal indicate that smooth muscle-derived vascular progenitor cells may play a role in driving atherosclerosis progression through expansion of the vasa vasorum and increased plaque neovascularization. The proposed research will create a more thorough understanding of the cellular mechanisms involved in atherosclerotic disease progression, which could prove valuable in the development of next-generation treatment approaches.